Combined Amikacin and Azithromycin in an Inhaled Formulation for the Treatment of NTM

Though important progresses have been made in the reducing the prevalence of Mycobacterium tuberculosis
infections in many regions of the world, non-tuberculous mycobacteria (NTM) continue to rise at an alarming
rate. The M. avium complex (MAC) is the primary cause of NTM infections, accounting for about half of all
cases. The current standard of care therapy for MAC includes a three-drug regimen of ethambutol, rifampicin,
and a macrolide, azithromycin or clarithromycin, with the addition of FDA-approved amikacin liposome
suspension for inhalation by nebulization for severe infections. Unfortunately, the current standard of care
therapy is suboptimal with a significant proportion of patients demonstrating persistent or progressive disease.
Moreover, azithromycin given orally is associated with complications including ototoxicity, prolongation of the
QT interval, a measurement of the time between the start of the Q-wave and the end of the T-wave in
electrocardiogram (ECG), and gastrointestinal symptoms. Amikacin as a nebulized liposomal preparation has
drawbacks as well, including the time required to deliver the therapy, the necessity to clean the nebulizer, and
the rupture of liposomes secondary to the method of delivery. Our overall goal is to develop an inhaled, fixed-
dose combination (I-FDC) powder product containing both azithromycin and amikacin using our proprietary
thin-film freeze-drying technology for delivering them as a single unit to the distal airways by oral inhalation.
We hypothesize that inhaled azithromycin and amikacin combination will improve MAC treatment outcomes by
increasing their concentrations simultaneously at the site of infection while decreasing their systemic exposure
and thus side effects. We have already developed several prototype excipient-free, fixed-dose combination
powders of azithromycin and amikacin at various weight ratios, with desirable aerosol performance properties
for lung delivery. To achieve our overall goal and to test our hypothesis, we propose the following three specific
aims: 1) to optimize the composition of the fixed-dose combination powders of azithromycin and amikacin and
determine the effect of the ratio of azithromycin and amikacin in the powders on their activity against M. avium
bacteria, both within and outside of macrophages; 2) to evaluate the pharmacokinetics and biodistribution of
azithromycin and amikacin in a mouse model when they are administered as a fixed-dose combination powder
into the lung; and 3) to assess the effectiveness of the optimized inhaled, fixed-dose combination powder of
azithromycin and amikacin in a mouse model with M. avium infection in the lung. As an outcome, we expect to
develop a novel effective inhaled combination therapy for MAC, a high mortality lung disease with limited
treatment options using the low-risk developmental approach of drug repurposing and a novel excipient-free,
inhaled pharmaceutical dry powder formulation of two antibiotics commonly used in MAC treatment. Similar
products may also be developed for other NTM infections.

Public health relevance
The proposed research is relevant to public health because we aim at developing and validating an inhaled, fixed-dose combination powder of two antibiotics to improve the treatment outcomes of non-tuberculosis mycobacterial (NTM) lung disease, which can cause damage to the lungs and make people critically ill. Therefore, the proposed research is relevant to the NIH’s mission of enhancing health, lengthening life, and reducing illness and disability.